Electrocardiogram-based deep learning and decision analysis to improve atrial fibrillation risk estimation

Project Summary/Abstract
Atrial fibrillation (AF) is a major public health problem resulting in preventable strokes and increased incidence
of heart failure and early cognitive decline. AF is expected to affect nearly 12 million people in the United States
by 2030. Oral anticoagulation (OAC) is highly effective in reducing risk of AF-related stroke, and other preventive
interventions such as weight loss, exercise, and alcohol cessation may reduce risk of AF and associated
complications. However, AF is commonly asymptomatic and is frequently episodic, and therefore may be difficult
to diagnose. Although screening can detect undiagnosed AF, mass screening approaches have not resulted in
meaningful improvements in clinical outcomes. A major inefficiency inherent within current screening approaches
is the screening of many individuals at relatively low risk for AF, leading to an inefficient and low-yield screening
intervention. Therefore, there is a critical unmet need to identify individuals at elevated risk of developing AF
upfront, in order to optimize the efficiency of AF screening and preventive interventions. In Aim 1 of this proposal,
we will develop and compare novel deep learning-based methods to estimate AF risk in an automated fashion
using mobile single-lead electrocardiograms. In Aim 2, we will conduct an individual-level simulation to quantify
the comparative and cost-effectiveness of a risk-based approach to AF screening, as compared to the current
clinical standard of AF screening based on the simple age cutoff of ³65 years. In Aim 3, we will perform a pilot
study to quantify the user acceptability of prospective AF risk estimation and quantify associations between
estimated AF risk and true AF incidence at 18 months. The overall goal of the K23 parent proposal is to establish
the feasibility and potential clinical value of automated AF risk estimation to guide preventive interventions
designed to reduce the morbidity resulting from AF and its associated complications. The aims will be executed
in the setting of a comprehensive career development program designed to provide Dr. Khurshid, an early career
investigator, with the skills and experience required to become an independent clinician investigator focused on
the improvement of outcomes in cardiac arrhythmias through the use of disease risk prediction. This proposal
impanels a multi-disciplinary team comprising experts in machine learning, decision science, and prospective
clinical studies, who will guide Dr. Khurshid in his transition to scientific independence. The purpose of the
administrative supplement is to support continued progress toward the pursuit of Dr. Khurshid’s scientific and
career objectives by providing critical analytical and logistical support to offset time lost due to a critical life event.

Public health relevance
Project Narrative Atrial fibrillation (AF) is a major public health problem resulting in preventable strokes and increased incidence of heart failure and early cognitive decline. Preventive interventions such as AF screening have potential to improve outcomes but appear inefficient when applied indiscriminately. In this proposal, we will develop novel deep learning-based methods to estimate AF risk in an automated fashion using mobile single-lead electrocardiograms, develop a comprehensive simulation to quantify the comparative effectiveness of a risk- based approach to AF screening, and perform a pilot study to quantify the user acceptability of prospective AF risk estimation and quantify associations between estimated AF risk and true AF incidence.